Research supplement to promote diversity within the context of research involving recovery community centers

Project Summary
The goal of this administrative supplement is to provide Dr. Felecia Pullen with a half-time fellowship to
contribute to the activities of the parent grant (R34 DA057604), and to engage in career development activities
to build towards her own independent research career. Dr. Felecia Pullen is the director of a recovery
community center (RCC), the PILLARS, located in Harlem, New York City. She completed her Ph.D. in May in
2022 at Fordham University, many years after she has been engaged in providing peer recovery support
services and founding her own RCC. Dr. Pullen has demonstrated interest in and passion for conducting
research in this space, as evidenced by her collaboration on local, state and federally-funded research
projects. These collaborations, however, have not provided her with the opportunity to publish in peer-
reviewed journals, or pursue NIH-level funding on her own. Dr. Bettina Hoeppner will serve as her primary
mentor during her proposed fellowship. The goal of this fellowship is to provide Dr. Pullen with the experience,
training, mentoring, and networking to enable her to conduct her own PI-led NIH-funded research and to
publish her research in scientific journals, while continuing to lead her RCC. The parent grant provides an
ideal context to achieve these goals. Namely, R34 DA057604 is a planning grant that seeks to prepare for a
large-scale effectiveness trial that can test the effectiveness of RCCs. RCCs are recovery-oriented
sanctuaries anchored in the hearts of communities, which provide a range of recovery-oriented, peer-delivered
services. Despite recent rapid largescale investment in their growth, empirical data on their functioning and
outcomes are extremely limited. Thus, our team is engaging in three preparatory studies that can inform the
design and logistics of a planned subsequent rigorous R01-level trial, which will test if linkage from clinics that
provide medications for opioid use disorder (MOUDs) to RCCs will result in improved recovery trajectories for
people using MOUDs. During the proposed fellowship, Dr. Pullen will engage in research activities as part of
the R34 team, including co-authorship on papers, while also engaging in mentored research activities to
advance two specific research projects of her choosing: (1) submitting an NIH grant application on testing the
acceptability, feasibility and efficacy of offering the SKY Recovery program via RCCs; and (2) testing and
publishing findings on the Mixed Method Recovery Capital Assessment Tool (MRCAT) developed by Dr.
Pullen. Additionally, Dr. Pullen will engage in scientific network building activities. Together, these activities
will optimally prepare Dr. Pullen for her next career step to conduct NIH-funded research alongside her active
leadership role in delivering recovery support services role. This increased expertise and reach will amplify her
ability to contribute to addressing and dismantling structural inequalities in the addiction and recovery space.

Public health relevance
Project Narrative This administrative supplement will provide Dr. Felecia Pullen with a half-time fellowship to provide her with the experience, training, mentoring, and networking to enable her to conduct NIH-funded research, while continuing to lead her own recovery community center. By training with Dr. Bettina Hoeppner within the context of this R34, she will expand her professional network, gain applied research skills, and receive mentoring to advance her scientific career.